Innovation of Skin Banking and Transplantation Based on a First-in-Class Biocompatible Cryopreservation Technology

SUMMARY
Previous support from NIH SBIR and Coulter Foundation awards allowed the CryoCrate team to develop a first-
in-class biocompatible cryopreservation medium product, trademarked as OdinSol®, that will provide efficient
options for biobanking practices associated with storage of skin grafts from donors or xenotransplants.
The OdinSol® technology removes the need for any toxic cell permeating cryoprotectant used in all existing
tissue cryopreservation methods, considerably simplifies associated operations, and more importantly, secures
the outcome of long-term storage in regular -80oC deep freezers by preventing gradual cell loss.
Based on our former experience in FDA 510(k) submission, in this project, we organized the collaboration with
our regulatory consultant (Cardinal Health), contract manufacturing organizations (Bryllan), contract research
organization (WuXi AppTec), academic collaborator (University of Missouri Department of Medicine and National
Swine Research and Research Center), to achieve the following milestones:
I. The production of OdinSol® meets GMP qualifications and biocompatibility assessment shows
compliance with FDA guidance for 510(k) submission as a storage device for transplantable tissues;
II. The in vitro and in vivo evaluation of safety and efficacy demonstrates the OdinSol® technology to be
superior to existing cryopreservation protocols with respect to preserving viability and function of skin
grafts;
III. Based on those qualifications, we will complete of the 510(k) submission and finalize of the production
line based on further FDA feedback before the end of the project period.
We expect future clinical use of the OdinSol® technology within three years after the FDA clearance, providing
the skin banking and xenotransplantation industry with a highly efficient biocompatible cryostorage platform.

Public health relevance
NARRATIVE The overall goal of the project is to secure Good Manufacturing Practice (GMP) production and FDA 510(k) clearance for a first-in-class “biocompatible” cryopreservation medium product, OdinSol®, that will not only significantly improve the efficiency in current biobanking of donor skin grafts but also pave the path to future practice of xenotransplantation.